Bridge to the Doctoral Degree University of Puerto Rico to Medicine and Dentistry

6. Project Summary/Abstract This proposal seeks to renew the Bridge to the Doctoral Degree: UPR to UMDNJ , which has been assisting underrepresented minority (URM) graduate students in making the transition from the M.S. Program in Biology at the University of Puerto Rico-Mayagüez Campus (UPR-M) into the Ph.D. Programs in the Molecular Biosciences at UMDNJ-Graduate School of Biomedical Sciences (GSBS), Piscataway Campus, offered jointly with Rutgers, The State University of New Jersey (RU). The M.S. in Biology Program at UPR-M has a student population that is predominantly Puerto Rican, but the Program does not offer a Ph.D. to prepare students for careers as senior investigators in the biomedical sciences. However, UPR-M has a long record of producing excellent candidates for the Ph.D. at other institutions, including at UMDNJ-GSBS, Piscataway, and RU. To facilitate the transition of M.S. candidates at UPR-M, this 3-year Program was established, consisting of one year of course work at UPR-M, followed by 2 years of course work and research at UMDNJ. Students completing this Bridge program receive the M.S. degree from UPR and are admitted with advanced standing into the Ph.D. programs at UMDNJ-GSBS, interfacing with the existing UMDNJ-Rutgers University Pipeline Program (IMSD Award), which supports URM candidates for the Ph.D. in their initial years of study. Now in the 9th year, we have enrolled 19 students in the program. Of these, 3 have completed the Ph.D., and 9 are progressing toward the M.S. or Ph.D. degrees. Among the 9 continuing students, 1 is at UPR-M and 8 are at UMDNJ, including 4 now at an advanced level of thesis research and 4 at the pre-qualifying exam phase. During the 8 years of the program, 7 students left the program during their first 3 years of study: 1 of these is in a Ph.D. program elsewhere, 2 entered medical school in PR, 1 is pursuing the M.S. at UPR-M, 2 are technical scientists and one is seeking scientific employment. None have left the biomedical sciences. We continue to modify the program to deal with issues of recruitment and selection of appropriate students, preparation at UPR-M, acclimatization during the transfer from UPR-M to UMDNJ, and program flexibility at UMDNJ. Based on the increased success rate of bridge students whose first research experience at UMDNJ preceded M.S. coursework at UPR-M, we propose to make an initial summer of research at UMDNJ as well as individual research at UPR-M integral parts of the program. This program continues to increase opportunities for talented Puerto Rican students at UPR-M, and to increase the number of URM students in the Ph.D. program of UMDNJ and Rutgers, thereby expanding the range of students entering biomedical research careers at the Ph.D. level, and creating a more nurturing environment for URM students at UMDNJ and RU. 7.

Public health relevance
Project Narrative There is a national shortage of underrepresented minority scientists in the biomedical sciences, which the Bridges to the Doctorate Program of the MORE Office of NIGMS was designed to address by enabling minority M.S. candidates from minority-serving schools to progress to Ph.D. candidacy at partner universities. This proposal enables M.S. candidates in Biology at University of Puerto Rico-Mayagüez Campus to matriculate into the Ph.D. programs in the Molecular Biosciences at University of Medicine and Dentistry of New Jersey- Graduate School of Biomedical Sciences, Piscataway Campus. This and other such programs should increase the diversity of the biomedical science workforce in the United States. A more diverse group of Ph.D.-level scientists in the U.S. should provide role models for more diverse trainees in the future, and should promote research into health issues of particular concern to minority communities. __SpecificAimsTextDelimiter__ 1. INTRODUCTION N/A 2. SPECIFIC AIMS 2.A. To Increase Rate of Progression of M.S. Candidates to the Ph.D. This Bridge is designed to increase the frequency of M.S. candidates in Biology at UPR-Mayagüez Campus continuing their education to obtain the Ph.D. The Bridge will contribute to this objective by improving recruitment of talented students into the M.S. program, increasing awareness in the students in this program of the prospects for them to obtain the Ph.D. and by assisting students in preparing to make the transition into the Ph.D. program at UMDNJ-Graduate School of Biomedical Sciences (GSBS), Piscataway Campus. This Bridge will be to the Ph.D. Programs in the Molecular BioSciences (MBS) of Rutgers University (RU) and UMDNJ- GSBS, although it is expected that the improved awareness and preparation may also result in increased student enrollment in other Ph.D. programs. We plan to admit two students into this program in each year of support. Objective 1. At least 80% of enrolled students should complete the M.S. degree and/or progress to the Ph.D. program by completion of the Bridge Program curriculum. Objective 2. At least 70% of enrolled students should make the transition to the Ph.D. program with advanced placement after three years in the Bridge Program, and progress to complete the Ph.D. 2.B. To Increase enrollment and retention of URM Ph.D. candidates at UMDNJ-GSBS, Piscataway This Bridge Program interfaces with the existing UMDNJ-RU Pipeline Program (supported by an Initiative to Maximize Student Diversity Award) to increase enrollment of URM Ph.D. candidates in the Molecular Biosciences Graduate Programs. The Pipeline Program addresses the needs of those URM students who know that they wish to pursue the doctorate, and who have sufficient preparation to pursue the flexible Ph.D. curriculum supported by the Pipeline Program. On the other hand, this still does not address students who, despite talent, are not yet academically prepared for the Ph.D. program, or who have not had adequate exposure to a doctoral program environment to realize that such a program is both possible and desirable for them. As mentioned in the Progress Report, most students who have been accepted and are progressing in the Bridge Program would not have been accepted directly into the Molecular Biosciences Ph.D. programs. However, the data suggest that the Bridge Program has effectively prepared a substantial percentage of our students to succeed in the coursework and research phases of the Molecular Biosciences Ph.D. program, including 3 who have been awarded the Ph.D. in the past two years. Although there is no appropriate control, support mechanisms of the Bridges Program clearly have contributed to this success. Furthermore, the research and course experience at the doctoral institution while in the M.S. program should serve to accelerate their progression through the Ph.D. program. During the next period of funding, the number of URM Ph.D. candidates and number receiving Ph.D. degrees will continue to increase from present levels. Considering the entire transit time for M.S. and Ph.D. to be about 6-7 years, with a recruitment of 2 students per year and a e 70% transition rate to the Ph.D., we expect during the next funding cycle to achieve a steady state of about 5-6 Ph.D. students and 3-4 M.S. students from this program during any academic year. These will add to the URM Ph.D. students recruited through our IMSD grant and from other admissions and funding mechanisms, including another Bridge to the Doctoral Degree Program based at nearby Montclair State University. At least 80% of the trainees will reach this goal, enroll in other Ph.D. programs, or achieve the M.S. and enter scientific careers.